Neural Mechanisms of Empathy Loss in Frontotemporal Dementia

Frontotemporal dementia (FTD) encompasses a spectrum of neurodegenerative diseases caused by focal
and progressive atrophy of frontal and/or temporal lobes and is the leading cause of dementia before the age
of 60 and the second most common form of dementia after Alzheimer’s disease (AD). There is no cure.
Among several variants within the FTD spectrum, the behavioral variant (bvFTD) is the most prevalent,
accounting for nearly 50% of all FTD cases. bvFTD is characterized by marked changes in personality,
impaired judgement and social conduct, and blunted emotion and affect, including a loss of empathy, which
represents arguably the most distressing and defining feature of bvFTD. The underlying neural mechanisms
are unknown. About 40-50% of FTD cases are familial and associated with mutations of over a dozen genes
with diverse molecular and cellular functions, among which GGGGCC (G4C2) hexanucleotide repeat
expansions (HREs) in the chromosome 9 open reading frame 72 (C9orf72, or C9) gene is the most common
genetic cause of FTD. We established an bvFTD mouse model of empathy loss and observed that aged
somatic transgenic mice expressing G4C2 HREs in C9orf72 exhibited blunted affect-sharing and failed to
comfort distressed conspecifics by affiliative touch. Our preliminary studies found that a marked reduction of
pyramidal neuron excitability in the dorsomedial prefrontal cortex (dmPFC) in aged mutant mice underlies
their lost empathy. Remarkably, restoring dmPFC neuronal excitability rescued the empathy deficits in mutant
mice, even at advanced ages when substantial cortical atrophy had occurred. These results establish dmPFC
hypoexcitability as a potential pathophysiological basis of empathy loss in bvFTD. The goals of this R01
application are to define the prefrontal circuits mediating empathy-driven consolation behavior (Aim 1),
delineate the intrinsic, synaptic, and circuit mechanisms of lost empathy in C9-bvFTD mouse models (Aim 2),
and explore therapeutic strategies that can rescue, reverse, and prevent empathy loss in mutant mice (Aim
3). The proposed studies are fundamentally important and highly significant because they have the
immediate potential to uncover novel pathogenic mechanisms and treatment strategies for FTD and related
dementia.

Public health relevance
The goals of this R01 are to elucidate the neural circuitry mechanisms underlying lost empathy, arguably the most distressing and defining feature of frontotemporal dementia (FTD), a leading form of presenile dementia, using newly established behavioral paradigms and bvFTD mouse models. Successful completion of the proposed experiments will fill a longstanding and critical gap in our understanding of the neural basis of empathy loss associated with behavioral variant FTD and uncover novel therapeutic strategies for FTD and related dementia.